Clinical epigenetic diagnostic for spermatogenic failure and future health risks

SUMMARY / ABSTRACT – Inherent Biosciences
Dr. Dolores Lamb from the Weill Cornell Medicine (WCM) has discovered a novel epi-
genetic source of male-infertility that has been shown to be the most common genetic source of
sperm impairment in men suffering for non-obstructive azoospermia (NOA). Inherent
Biosciences in collaboration with WCM proposes the development of a cost-effective
commercial diagnostic for use in genetic testing of incoming patients at the Department of
Urology at WCM.
Prior to this discovery, Klinefelter’s syndrome and Y chromosome microdeletions were
the two most prevalent genetic causes of male infertility. Klinefelter’s syndrome and Y
chromosome microdeletions account for 11% and 8% respectively in azoospermic men.
According to the current AUA/ ASRM Guidelines, genetic testing for both Klinefelter’s syndrome
and Y-chromosome microdeletion is recommended for all men with severe oligospermia or
azoospermia to clarify etiology of male infertility prior to treatment (market size of 12.2 million
men worldwide).
Work from the Lamb Lab over the last 20 years has identified epigenetic mutations in
men at specific sites within the DNA/mismatch repair genes (MMRs) accounting for 17% of men
with dysfunctional sperm production (twice as frequent as Y chromosome microdeletions). Once
commercially available and clinically validated in the Department of Urology at WCM, we believe
this test will become one of the ASRM/AUA recommended genetic tests for all men with severe
oligospermia or azoospermia. Phase 1 of the SBIR study will focus on 1) developing a highly
accurate and cost-effective targeted sequencing assay for analysis of the novel epigenetic
mutations identified by Dr. Lamb and 2) validating the assay in a CAP/CLIA laboratory using
200 samples from WCM. Phase 2 of this proposal will be dedicated to the development and
commercialization of an LDT assay for use on all NOA patients treated at WCM.

Public health relevance
NARRATIVE – Inherent Biosciences NOA is the most severe form of male factor infertility where no sperm are in the ejaculate due to failure of spermatogenesis. Despite all of the current tools, men are still most commonly diagnoses with an “idiopathic” cause of NOA. Accordingly, understanding the genetic and epigenetic causes of NOA is an important problem to solve in reproductive medicine. Weill Cornell Medicine (WCM) has discovered a novel epigenetic etiology for non- obstructive azoospermia (NOA) that is more prevalent than all known genetic causes of NOA. Inherent Biosciences in collaboration with WCM proposes the development of a cost-effective commercial diagnostic for use in testing all incoming NOA patients of the Department of Urology at WCM, ultimately with the goal of becoming standard-of-care for NOA patients.